Structure-based Discovery of Critical Vulnerabilities of Mycobacteria

Project Summary – Overall
The TB Structural Genomics Consortium (TBSGC) is a collaborative research group that has
studied TB’s causative organism, Mycobacterium tuberculosis (Mtb), for the past 15 years. Over
the years we have focused our goals to concentrate on proteins that are drug targets for novel
antibiotics, and proteins whose structure might contribute to our knowledge of vulnerabilities in
Mtb. We also supplemented our structural work with both chemistry and genetics to validate our
targets, to obtain and optimize protein inhibitors, and to determine their underlying biological roles
within Mtb. Our multidisciplinary approach has allowed us to add considerable knowledge to
mycobacterial structures, and to leverage this information to inform drug development.
Significantly, results of the last TBSGC cycle has led to a novel anti-TB drug that is in late pre-
clinical development along with others compounds that have been adopted by anti-TB drug
developers.
In this TBSGC renewal, we propose to incorporate new innovative technologies, including
membrane protein structures and cryo-EM, to strengthen our commitment to TB drug
development. We will leverage structure determination to both understand function and identify
potential small molecule inhibitors. The fundamental goal of this project is to accelerate TB drug
discovery by understanding essential functions of the mycobacterial cell and providing validated
targets and inhibitors to our partners in the TB drug development community.

Public health relevance
Overall Project Narrative The TB Structural Genomics Consortium (TBSGC) focuses on leveraging protein structural information to understand TB biology, characterize novel drug targets and, ultimately, assisting in the development of new antituberculous agents. The TBSGC uses extensive genetic and chemical genetic information to concentrate its structural biology resources on key “vulnerabilities” in Mycobacterium tuberculosis, as these represent known or potential drug targets. In addition, we have expanded our expertise to include structure determination of membrane proteins (a class of proteins that was previously too technically difficult to solve), and of large macromolecular complexes via Cryo-EM.